UAB CFRC Administrative Core

PROJECT SUMMARY/ABSTRACT
The UAB Cystic Fibrosis Research and Translation Core Center Administrative Core is responsible for the
overall administration and coordination of the Biomedical Research Cores, Pilot & Feasibility Program, and
Enrichment Program. The Administrative Core is directed by Drs. Bedwell (P30 Director) Birket, and Solomon
(Associate Directors), along with continued involvement from Dr. Rowe (Associate Director) that additionally
serves to assure a seamless partnership with initiatives from the CF Foundation. Dr. Guimbellot will serve as
Co-Director of the Enrichment Program with Dr. Birket. Under this leadership, with assistance from the
experienced Research Management and Administrative Team (including Mr. Jeffrey Allison, Center
Administrative Director, and Dr. Emily Falk-Libby, Program Director-Scientific Affairs), the Core will continue to
successfully support CF Center goals in the upcoming funding cycle by: 1) Establishing the overall scientific
direction of the UAB P30 CF Center and ensuring continued contributions and growth into the most relevant
disease areas, including application of genetic therapies (e.g., directing communications between the
Administrative Core, P30 investigators, members of the Center’s active Internal Advisory Board, and/or
external consultants on its External Advisory Board to review Center activities and identify research directions
and opportunities), 2) Facilitating the objectives of all P30 components (e.g., prioritizing Core resources and
new equipment acquisition for optimal utilization, overseeing new state-of-the-art Core research space and
facilities, coordinating training and professional development activities, maintaining a Center website,
overseeing membership, building the Biomedical Core research base and monitoring its productivity,
supporting internal and external collaborations, managing successful operations in COVID-19), and 3)
Integrating P30 components with other UAB NIH Centers (e.g., promoting and sharing its innovative resources
and communicating with other Center leadership such as the Center for Clinical and Translational Science
(UAB’s CTSA site), NIDDK-Diabetes Research and Training Center, NIDDK-Nutrition Obesity Research
Center, and NIDDK-Hepatorenal Fibrocystic Diseases Core Center) to identify continued opportunities for
multidisciplinary collaboration. In addition, specifically in support of the Center’s Enrichment and Pilot &
Feasibility Programs, the Administrative Core will continue to identify and integrate resources offered through
the Institution to maximize trainee success and transition to independence for junior faculty as well as to apply
its established, robust mechanisms for solicitation, review, and oversight of P30 pilot applications to foster new
and important contributions to CF science. Overall, it is the goal of the Administrative Core to optimally
promote synergy and progress within the CF P30 Center.